Core B: Molecular Pathology and Bioinformatics Core

CORE B ABSTRACT
Molecular Pathology and Bioinformatics Core
Core Director: Michael Berger, PhD (MSK)
The Molecular Pathology and Bioinformatics Core will work closely with all Project teams to coordinate the
procurement and analysis of patient-derived tumor and matched normal tissue prioritized for further
characterization to fulfill the Research Aims. Biospecimens from selected patients will be obtained from
participating AACR GENIE sites and characterized centrally by the Core. Digital pathology imaging and nucleic
acid extraction will be performed from FFPE tissue specimens using standardized protocols. Comprehensive
genomic platforms, including whole exome sequencing and RNA-Seq, will be run under the direct supervision
of the Core Director to enable deeper, multi-omic characterization of samples previously tested using targeted
DNA panels. State-of-the-art bioinformatics pipelines will be used to produce and disseminate results to Project
teams, and Core members will collaborate with each Project to provide customized analytics support directed
to the individual Aims.

Public health relevance
CORE B NARRATIVE The Molecular Pathology and Bioinformatics Core will perform deep molecular characterization of tumors collected from patients across all participating cancer centers to identify DNA- and RNA-based features that correlate with clinical outcomes. In line with the goals of the Research Projects, we will select and prioritize tumors representing underrepresented populations, subclasses of patients who have received immunotherapy, and ERBB2 and BRAF fusion cancer types, and that benefit from coordinated efforts across many institutions to adequately study.